Eradication of brain/CNS HIV reservoirs via anti-HIV gene-modified macrophages

PROJECT SUMMARY
Combination antiretroviral therapy (cART) is highly effective, but it is weakened in the central nervous
system (CNS) due to poor drug penetration. In addition, cells infected by HIV in the CNS - termed “CNS
reservoirs” - are mainly constituted by myeloid lineage cells, such as microglia cells and macrophages, thus anti-
HIV strategies employed are needed to be adapted to these cell types. Various approaches have been applied
for controlling viral load in the CNS - for example, T cells expressing anti-HIV chimeric antigen receptor (CAR-
T) or broadly neutralizing antibodies (bNAb) – and these approaches effectively target HIV or HIV-infected cells
systemically but are ineffective against the CNS reservoirs since cytotoxic-T cells cannot attack myeloid-lineage
cells well and antibody penetration into the CNS is extremely low. As such, there is no practical approach
successful enough to eliminate these reservoirs safely.
We here intend to purge the CNS reservoirs via using genetically modified macrophages expressing anti-
HIV CARs (CAR-M) (Aim 1) and multidirectional bNAb (bNAb-M) (Aim 2). Both will be expressed in freshly
isolated monocytes from blood sources as a carrier vehicle to the CNS and an effector cell. Importantly,
monocytes will be recruited to the CNS when neuroinflammation occurs; HIV infection itself as well as some
antiretroviral drugs such as Tenofovir disoproxil fumarate (TDF) or nevirapine (NVP), are known mediators of
neuronal inflammation. To overcome the issue of HIV quasispecies, we will use each tool to target several
different epitopes, i.e., express 2 or more anti-HIV CARs in the same cells (Aim 1) or multidirectional bNAbs in
one molecule which target 3 independent epitopes on the HIV envelope protein (Aim 2). In addition, to protect
the gene-modified monocytes, we will simultaneously express two anti-HIV genes with these immunotherapeutic
tools; a) C46 that interferes fusion between HIV envelope and cellular membranes, thus blocking HIV infections
and b) shRNA against HIV LTR (sh516) that destructs all HIV transcripts including the sequence derived from
HIV LTR. Altogether, our approach will ensure CNS delivery of monocytes following gene modification to express
multiple anti-HIV CARs or multidirectional bNAbs whilst protecting from HIV infections and/or productions. The
monocytes will then differentiate into macrophages in the CNS and attack the infected cells via anti-HIV CAR
(CAR-M) or secreting multidirectional bNAbs (bNAb-M) inducing antibody-dependent cytotoxicity or
phagocytosis (ADCC/ADCP) against the infected cells. In case of the bNAb-M approach, secreted bNAbs will
also work on adjacent myeloid cells which support both ADCC/ADCP. In addition, the bNAbs will neutralize new
HIV infection. As such, our approach is highly unique, and, if successful, will open a new avenue to defeat HIV
reservoirs in the CNS.

Public health relevance
PROJECT NARRATIVE: Although anti-HIV CARs or bNAbs have tremendous potential for HIV cures, they cannot efficiently penetrate the CNS where HIV reservoirs are present. Overcoming this challenge would remove one of the major barriers for controlling as well as eliminating reservoirs in the CNS. We propose to utilize macrophages ex-vivo modified to express anti-HIV-CAR or bNAbs, which naturally tend to migrate to the brain/CNS with HIV infections.